ESR MICROSCOPE MAIN MAGNET POWER SUPPLY UPGRADE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We have acquired a state-of-the-art precision high-power switching power supply (15KW Lambda Genesys series) to replace the older Varian 5KW linear supply presently employed as the main magnet power source for the 16GHz ESR pulse microscope. The replacement switching power supply provides a low-noise, well-regulated output in a very high power density package that includes a number of I/O options for direct computer and LAN control. A thorough investigation of radiated and conducted radiofrequency noise for this power supply series has resulted in the vendor's supplying supplemental qualifying proof of its suitability for sensitive applications such as NMR and ESR. This supply will be incorporated into a host computer programmable regulation system consisting of the current Hall system (based on Lakeshore 475) and a proprietary field/frequency lock (FFL) r.f. detector/processor. In fall of 2008 this system will replace the existing FFL patch (Varian)/magnet power source. A second, similar 15KW power supply has been acquired for the 35GHz ESRM magnet, which will also utilize a hybrid Hall/FFL field regulation system. Consequently, our expectation is that the experience in design, construction and implementation of the first field-regulated magnet power source will be gainfully applied to the second system intended for the 35GHz ESR microscope.